Food for thought: a virus-like signal for the energetic demands of higher cognitive functions

To maintain organismal energy balance, energy molecules extracted from the diet or liberated from
stored forms must be distributed appropriately throughout the body. By integrating and distributing
signals to and from disparate tissues and organs, the brain plays a major role as a command center
in organismal energy balance. The brain is also a hungry organ, consuming a disproportionate
amount of energy relative to its size. Higher-level cognitive functions like learning and forming
memories burn even more energy. Energy imbalance, such as a chronic high-calorie diet, perturbs
cognitive functions like learning and memory, but the underlying mechanism is not clear. Metabolic
syndromes like obesity are also associated with neurodevelopmental and neurodegenerative
disorders. Most studies of organismal energy balance focus on how the brain uses a few known
pathways to mediate inter-organ communication, but it is not known how cognitive functions
specifically signal the brain’s demand for fuel and mobilize energy from stores in other parts of the
body. The proposed studies test an entirely new model in which virus-like particles synthesized during
learning/memory activity in brain neurons travel to fat storage tissues and induce mobilization of
stored energy. Arc (activity-regulated cytoskeleton-associated protein) was known for decades to be
induced by learning/memory activity in neurons, where Arc oligomers promote synaptic activity and
plasticity. Arc proteins evolved from a retrovirus and retained the ability to assemble into virus-like
capsids that spread from cell to cell. A ground-breaking hypothesis to be tested here proposes that
Arc capsids travel from the brain to fat storage cells, where they signal brain activity and trigger
release of energy into circulation. Levels of circulating energy feed back onto Arc expression via
metabolic control of N6-methyladenosine (m6A) modification of Arc mRNA. Together, these coupled
processes are proposed to comprise a homeostatic circuit that integrates the brain’s need for fuel and
maintains organismal energy balance. The experimental system addresses the basic features of this
circuit from the behavioral to the molecular level, including a conserved requirement for Arc in
associative learning and cognitive dysfunction when excess dietary calories overwhelm the system.
The planned research will determine properties of Arc required for communication with fat storage
cells and how it alters organismal metabolism to supply energy to the brain. Other experiments will
identify the key components of diet that alter m6A modification and virus-like Arc assembly and test
custom diets designed to ameliorate cognitive dysfunction. This project will establish the mechanistic
details of a previously unknown brain–adipose signaling axis and a homeostatic circuit where
uncoupling leads to neurodevelopmental and neurodegenerative disease.

Public health relevance
The brain consumes a disproportionate amount of energy, and it is not known how the brain balances its energetic needs with those of the rest of the body. Proposed studies investigate a mechanism by which a protein that evolved from a virus directly transmits needs from the brain to fat storage cells. The goal is to transform our understanding of how energy imbalance, such as in obesity, perturbs neurodevelopment and cognitive functions.